Ohio State University Wexner Medical Center R25 Neurological Surgery Resident Research Training Program

ABSTRACT
Over 1 billion people around the world will be significantly impacted by a neurological disorder during their
lifetime. Better understanding of the underlying pathobiological mechanisms and the development of new
treatment paradigms is critical to mitigate the impact and/or cure these diseases. Neurosurgeon-scientists
have a unique opportunity to fundamentally advance understanding into ineffectively treated or untreatable
neurologic disorders. Specifically, neurosurgeons can directly access human physiologic data, acquire
nervous system lesions/tissue, develop/employ new surgical treatment technology, as well as make direct
associations between the operating room and clinical findings. Moreover, they have the potential to
collaborate with scientists from other disciplines to most effectively advance critical discoveries and develop
new therapeutic paradigms. Consequently, defined and robust training of neurosurgeon-scientists is urgently
needed.
To enhance research training and best support the successful transition from residency to an independent
neurosurgeon-scientist career, we are applying for National Institute of Neurological Disorders and Stroke
(NINDS) R25 in Neurological Surgery at the Ohio State University (OSU). The overarching objective of this
program is to provide research training to neurosurgery residents in the basic, translational and/or clinic
sciences that will drive their successful transition to independent National Institutes of Health (NIH) funded
neurosurgeon-scientists after residency. This program is led by 2 senior investigators (Drs. Herson and
Lonser) who have implemented a research curriculum and programmatic changes to maximize the impact of
the R25 on selected neurosurgery residents at OSU. The training plan is supported by senior faculty with a
track record of mentoring/funding success and leverages the research infrastructure across the OSU campus.

Public health relevance
PROJECT NARRATIVE The current proposal is a new resident research training program in the Department of Neurological Surgery at the OSU. There is critical need to enhance biomedical and clinical research training to develop and retain clinician-scientists, particularly in the field of neurosurgery. The broad objectives of this training program are to provide training to neurological surgery residents in the clinical, translational and basic sciences.